Mechanism of initiation of lipid binding of apolipoprotein A-I

Project Summary
Apolipoprotein (apo) A-I is a multifunctional protein with a well-established role in reverse
cholesterol transport and is an important player in heart disease. It is the main protein
component of high-density lipoprotein (HDL), which circulates through plasma promoting
cholesterol efflux. While a high-resolution structure is not known yet, extensive biophysical
analysis has suggested that the 28 kDa protein is made of two domains, each of which contain
amphipathic α-helices for association with lipid surfaces. The C-terminal (CT) domain contains
helical segments that initiate lipid binding, and is also the site responsible for self-association. It
is a critical part of the protein needed for maturation of lipid-free apoA-I into HDL. Conflicting
data exist about the role of the N-terminal (NT) helices in this process, as well as the precise
helical segments of the CT domain. We have recently discovered that CT lysine residues are
critical for self-association, and were able to create a monomeric version of the protein. To
identify apoA-I helical segments important for initiation of lipid binding and self-association,
which are closely connected, we developed a chimeric protein. This chimera will be used to
identify which helical segments of apoA-I, both NT and CT α-helices, are required for initiation of
lipid binding and self-association. To identify the specific amino acid residues of the CT domain
required in self-association, site-directed mutagenesis will be employed. All proteins will be
expressed in a bacterial expression system, purified by affinity and size-exclusion
chromatography, and characterized for structure and function. The results of this study will lead
to a much better understanding in the domain organization of this critical apolipoprotein, their
structure function relationship, and may also provide opportunities for high-resolution structural
analysis using monomeric apoA-I.

Public health relevance
Narrative Apolipoprotein A-I is an exchangeable apolipoprotein well known for its antiatherogenic properties. The proposal aims to understand the structural requirements of apolipoprotein A-I for self-association and initiation of lipid binding, which is critical for formation of high-density lipoprotein. A better understanding of apolipoprotein A-I lipid binding can lead to improved strategies to prevent or manage atherosclerosis.